Towards a neurobiology of "oromanual" motor control: behavioral analysis and neural mechanisms

PROJECT SUMMARY
The goal of this proposal is to develop new methods to study the neurobiology of “oromanual” motor control –
goal-directed, coordinated movements of jaw- and hand-related structures, as exemplified by food-handling
behavior, a natural and ethologically essential activity. Movements of the hands and jaw have traditionally been
studied entirely separately – e.g. actions such as reach-to-grasp and mastication, respectively. Yet many
mammals, especially primates and rodents, use coordinated hand-and-jaw movements for natural behaviors,
particularly food handling. Neither the precise kinematics of coordinated hand-jaw movements nor the underlying
neural mechanisms are well understood. Here we propose a research program that will begin to address this
gap in knowledge through a series of exploratory activities. During oromanual food-handling, electromyography
methods will be used to concurrently record masseter and forelimb activity, together with machine learning-
assisted tracking of movements captured by kilohertz video. Both head-fixed and freely moving paradigms will
be developed, to enable implementation of electrophysiological and optical recordings of neural activity across
motor/frontal cortical areas during food-handling. Cortical activity will be analyzed in relation to distinct behavioral
modes and sub-movements, and inform how active units contribute as a population to the overall cortical activity
pattern and hand-jaw interactions. Circuit-mapping paradigms will be developed to dissect the circuits mediating
communication along masseter- and/or forelimb-related corticobulbar pathways impinging on masseter motor
neurons in the motor trigeminal nucleus. The overall outcome will be a novel suite of tools, experimental
paradigms, and conceptual framework to enable future in-depth investigation of oromanual motor control.

Public health relevance
NARRATIVE The proposed research on oromanual behavior and its neural mechanisms is relevant to public health, both for advancing fundamental neuroscience knowledge about mammalian brain function and because a wide spectrum of common disorders affect these circuits in humans. The proposed research is thus relevant to those aspects of the NIH mission aimed at improving health through understanding pathophysiological mechanisms in disorders causing disability.